Synthetic mucins in epithelial models to probe virus-mucin interactions

Mucin glycoproteins are the essential component of mucus and the epithelial cellular glycocalyx. Mucins are essential for life in creatures from jellyfish to humans and play roles in hydration, lubrication, nutrient absorption, and host defense against pathogens. Mucin glycosylation is regulated by complex enzymatic pathways subject to flux, resulting in heterogeneous and variable glycan patterns that vary between tissues and species, and that evolve in response to diet and disease. The Kramer Lab is developing synthetic mucins, or synMUCs, that harness the chemical and biophysical properties of native mucins but have molecularly tunable structures. Polymerization of glycosylated amino acid N-carboxyanhydrides affords high molecular weight polypeptides with the native peptide and glycan linkages. Compared to short peptides, polysaccharides, or traditional polymers bearing attached sugars, synMUCs are the most authentic mucin mimics to date. The synMUCs will be applied in engineered models of the glycocalyx and secreted mucus. These models will find broad future application in studies of epithelial biology with application in cancer, drug delivery, immunity, and infection. Since mucins are on the front lines of cellular defense, viruses have evolved strategies to adhere to their glycans, alter them, and even use them to enter host cells for replication. Virus-mucin binding can have outcomes on viral diffusion, tissue specificity, and replication but molecular details are lacking due to mucin heterogeneity. We will chemoenzymatically modify our synMUCs to display virus-binding sialic acid glycans. Viral binding preferences for various sialic acid structures in different densities and from varied peptide backbone compositions will be defined. The sialic-acid-bearing-synMUCs will be utilized to probe how mucins in the glycocalyx vs mucus regulate adhesion, cell entry and replication, tissue tropism and viral gene evolution. This knowledge will shed light on fundamental aspects of the viral life cycle and may assist in improving human health though development of new antiviral therapeutics and disease transmission prevention strategies.

Public health relevance
PROJECT NARRATIVE Mucin proteins comprise mucus, which coats the surface of all epithelial cells for hydration and pathogen defense. Diverse viruses have evolved to attach directly to mucins, but due to varied mucin forms, molecular details of binding preferences and their outcomes on viral evolution, diffusion, tissue specificity, and replication are lacking. We will develop synthetic mucins of precisely defined structure to unravel how viruses interact with host cell surfaces, which will improve our understanding of viral diseases and open doors to new therapeutics.